Dissemination Core

Abstract - DISSEMINATION COMPONENT
An essential part of any database designed as a central resource for a community is dedicated user support to
provide documentation, training and outreach to the scientific community to promote the use of the resource
and gather user feedback. The specific aims of the Dissemination Component are to (1) provide training and
user support. We will provide training and assistance to our users in a variety of ways, including maintenance
of online user documentation, presentation of training workshops and demonstrations, webinars and remote
tutorials, and one-on-one assistance via a “help desk”. We will (2) expand access and dissemination. We
will add new ways to communicate with and include the community of developmental biologists and gene
expression analysts in the evolution and progress of the GXD resource. We will extend our outreach efforts to
human geneticists and other medically-oriented researchers.